PHASE I TRIAL OF ORAL TENIDAP COMPARING HEALTHY TO RENAL INSUFFICIENCY

Compare the dispotion of tenidap at steady state in subjects with varying degrees of renal insufficiency. In addition, effect of tenidap on the protein/ creatinine ratio in patients with varying degrees of renal insufficiency will be evaluated.